A chemical strategy for inhibiting Vibrio quorum sensing and virulence.

PROJECT SUMMARY
Rates of the human disease vibriosis caused by Vibrio bacterial infections are steadily increasing world-
wide due to rising ocean temperatures, surges in Vibrio abundance, and broader bacterial distribution in
aquatic ecosystems. Due to multi-drug resistance, there is an urgent need to develop alternative and
innovative strategies beyond standard antibiotics for treating Vibrio infections. A major pathway that drives
pathogenesis in Vibrios is quorum sensing (QS): bacterial cell-cell chemical communication. QS signaling
culminates in the production of a TetR-type master transcription factor collectively called the SmcR family,
which regulates genes required for infection of host organisms. Thus, it is postulated that SmcR-type proteins
are optimal targets for drug development to inhibit QS and treat vibriosis. Previous work by the van Kessel
group showed that thiophenesulfonamide compounds such as PTSP (3-phenyl-1-(thiophen-2-ylsulfonyl)-1H-
pyrazole) are potent and specific inhibitors that bind in the ligand binding pocket of SmcR-type proteins in
multiple Vibrio pathogens. The long-term goal of this work is to develop PTSP and its derivatives into potent
anti-QS molecules that treat vibriosis infections in humans. The van Kessel and Paczkowski groups
collaborated on structure-function analyses to identify PTSP-interacting residues in the ligand binding pocket
required for inhibition of SmcR activity in vivo. The results show that thiophenesulfonamides specifically bind
SmcR proteins in multiple Vibrios, alter the conformation of the DNA binding domain, and promote protein
degradation, thereby suppressing downstream gene expression. Collectively, these substantial preliminary
data implicate ligand binding as a mediator of SmcR protein stability to govern virulence gene expression in
Vibrio pathogens. However, the ligand binding pocket of SmcR proteins differ widely among Vibrios and the
native ligand for the SmcR family of proteins is unknown. Thus, optimal inhibitor design for multiple Vibrio
species will require a thorough understanding of SmcR-ligand interactions. The central hypothesis is that the
active conformation of SmcR is driven by native ligand binding. The objective of this proposal is to use
computational, biochemical, genetic, and biophysical assays to determine the interactions that drive SmcR-
ligand specificity via three aims: 1) perform structure-activity relationship analyses of a thiophenesulfonamide
library against the SmcR family, 2) determine the structural basis of ligand-induced conformational changes in
SmcR proteins, and 3) identify the native ligand(s) of SmcR. These experiments will determine the molecular
changes to Vibrio SmcR proteins induced by ligand binding, which will facilitate inhibitor optimization to
enhance efficacy, stability, and pharmacokinetic properties for drug design treatments for vibriosis disease.

Public health relevance
PROJECT NARRATIVE Vibrio bacteria are abundant in marine waters world-wide and cause vibriosis disease in humans by ingestion of contaminated raw seafood or via contact of open wounds with water. These bacteria use a cell-cell communication process called quorum sensing to control genes required for pathogenesis, and thus blocking quorum sensing leads to decreased Vibrio infections and disease. The proposed experiments will determine the molecular mechanism of a class of chemical inhibitors that block quorum sensing in Vibrio species, thereby establishing the efficacy of these compounds as treatment for Vibrio infections.